Engineering Receptors to Control Platelet Activation and Therapeutic Release

PROJECT SUMMARY:
While the use of living cells as therapeutic delivery vehicles has become a prominent area of focus in recent
years, challenges remain in achieving clinical translation due to limitations on available therapeutic loading
methods as well as lack of controlled therapeutic release mechanisms. Platelets offer a unique delivery platform
as they are anucleate cells naturally loaded with proteins from their megakaryocyte precursor cells, and release
their intracellular contents once activated. We have shown that megakaryocytes can be loaded with proteins that
are packaged into platelets, creating engineered platelets that function as novel delivery devices. However, a
key challenge remains that the native activation pathway of platelets may cause the activation and subsequent
release of therapeutic payloads in undesired locations. Thus, there is a critical need for a controllable activation
trigger in engineered platelets, specifically, one that is orthogonal to the native activation pathway. Here, we
engineered a set of novel platelet receptors that can be activated only by a pharmacologically inert small
molecule drug to enable the controlled release of the therapeutic payload carried by engineered platelets.

Public health relevance
PROJECT NARRATIVE: Cell-based therapeutic delivery systems have shown great clinical potential for treating a number of diseases, heart disease, lymphoma, and multiple myeloma. This project will develop engineered platelets as a therapeutic platform for disease treatment by allowing for their controlled spatiotemporal activation and drug release.